Development of 12-Lipoxygenase Inhibitors for diabetes treatment.

Approximately 25% of US Veterans have diabetes and the annual mortality rate due to diabetes in Veterans is almost
double of the rate in Veterans without diabetes. The presence of diabetes in the Veteran population is an important cause
of disability due to complications such as cardiovascular disease, neuropathy, retinopathy, and kidney disease. Recent
studies have indicated higher rates of new onset diabetes in Veterans who have had COVID-19 and analysis of Veterans
using the Million Veteran Database indicate a growing identification of new onset type 1 diabetes (T1D) in adults. Almost
half of the newly diagnosed cases of T1D are adults and there is an unmet medical need to identify treatments to prevent
or halt progression of the disease.
12-lipoxygenase (12-LOX) is a lipid-generating enzyme produced by various sites including pancreatic islet beta cells. 12-
LOX expression is elevated in obesity, Type 2 diabetes ( T2D) and T1D. We showed that 12-LOX protein is increased in
islets of auto-antibody-positive and Type 1 and Type 2 individuals. 12-LOX products are highly pro-inﬂammatory and
reduce pancreatic beta cell function and viability. 12-LOX lipids lead to oxidative and endoplasmic reticulum stress and
macrophage activation. Genetic deletion of 12-LOX in mouse models improves insulin signaling and prevents T1D
development. We earlier discovered a highly selective 12-LOX inhibitor, ML-355, through a comprehensive screening,
followed by iterative medicinal chemistry optimization. ML-355 has been licensed and pre-clinical and phase 1 safety
testing has been successfully completed and found to be safe. ML-355 is in a phase 2 clinical trial for intravenous
administration for a hematologic indication as the inhibitor is not suﬃciently orally bio-available for chronic diabetes use.
We recently discovered a new 12-LOX inhibitor, Slug001, which manifests increased potency both in vitro and in rescuing
inﬂamed human islet cells, relative to ML355.
We propose to explore this novel structural space with a suite of modiﬁcations of Slug001, guided by our computational
modeling of ML355 docking. The goal in Aim 1 is to derivatize Slug001 and ﬁll the active site cavity more eﬃciently so that
the inhibitor potency can be increased more than its current 7-fold improvement relative to ML355 and have improved
oral bioavailability. The docking model will greatly enhance the identiﬁcation of promising new inhibitors. Of the six
Slug001 lead derivatives, we have already synthesized several and shown that Slug002 is as potent as Slug001 but has
better solubility. The completed studies will generate novel inhibitors and a new VA patent.
In Aim 1 of the proposal, we will synthesize the new molecules and measure their potency and selectivity. Established
methods, comparing potency with docking scores, will allow us to quickly design these derivatives, increase their potency
and then subject them to our human diabetic cellular assays established in Aim 2. The derivatives of Slug001 will be
screened by the Holman laboratory against the LOX isozymes (5-LOX, 12-LOX, 15-LOX-1, 15-LOX-2) to establish their
selectivity.
In Aim 2 we will test the efficacy of the inhibitors in a reliable and novel human functional Islet beta cell line and then
move to testing in primary cadaveric human pancreatic islets. The testing will utilize using our established and validated
assays to test effects on insulin secretion and protection from cytokine mediated damage. Our expectation at the
completion of this pilot, is to move the lead compound (s) into a novel in humanized 12-LOX mouse model of T1D that
will facilitate rapid translation to clinical testing. The proposed project will provide a new way to address the high rates
of adult-onset Type 1 diabetes and complications in the Veteran population.

Public health relevance
Project Narrative Approximately 25 percent of veterans have diabetes, and the annual mortality rate is 5 percent, which are both higher than the non-veteran population. Recent evidence, arising from the Million Veterans Program and tracking veterans after SARS-CoV2 infection, indicates a significant rise in new onset diabetes with characteristics of immune-mediated type 1 diabetes. The 12- Lipoxygenase (12-LOX) protein is a viable target to prevent or even reverse pancreatic beta cell damage in diabetes. This project will advance the discovery and testing of promising new 12-LOX selective small molecule inhibitors to move into in vivo testing to prevent inflammatory mediated pancreatic beta cell damage. The development of selected 12-LOX inhibitors will provide a major advance to prevent and treat diabetes thus improving veteran health in the U.S.